Summer Biomechanics, Bioengineering, and Biotransport Conference

PROJECT SUMMARY
This proposal seeks NIH support for the 2022-2024 Summer Biomechanics, Bioengineering, and
Biotransport Conferences (SB3C). SB3C fills an important niche by providing a broad based, mid-sized
meeting focused on bioengineering. The SB3C program includes plenary, oral, and poster sessions
covering scientific content in Cell and Tissue Mechanics, Fluid Mechanics, Biotransport, Design and
Rehabilitation, Solid Mechanics, and Education. SB3C offers interactive workshops on topics including
professional development, novel educational approaches, and advanced research techniques.
The primary objective of SB3C is to promote state-of-the-art research, collaboration, and scientific
discourse in bioengineering. SB3C is a student-focused conference, with students comprising around
50% of attendees. Students at all levels can participate in the Student Paper Competition; network with
established investigators at the Diversity Mentor-Mentee Event or the Women’s Networking Event; and
enjoy social interactions with peers through activities organized by the Student Leadership Committee.
SB3C awards Diversity Travel Grants to enable students from underrepresented groups in biomechanics
to attend the conference and also keeps student registration fees low by seeking support from NIH, NSF,
and industry and academic sponsors.
The 2022 SB3C Organizing Committee is a diverse group of experienced SB3C organizers and
emerging leaders in biomechanics. We will continue successful scientific and diversity programs and
innovate in several ways , including:
• Creating a hybrid meeting with in-person talks, posters, workshops, networking and social events
as well as virtual content, including recordings of in-person plenary lectures and oral sessions as
well as online posters.
• Advertising the meeting and its content to faculty and students at community colleges, primarily
undergraduate institutions, and historically black colleges and universities. We will organize
networking sessions between these attendees and participants from the in-person conference to
enhance diversity in the graduate school pipeline.
The specific aim of this proposal is to support student participation in SB3C 2022-2024, with the goal
of increasing the number of student attendees who come from groups traditionally underrepresented in
bioengineering. We seek financial support from NIH to reduce virtual content registration fees for students
who cannot attend the in-person conference. We are confident that we can create a high-quality in-person
conference with high-quality virtual content, which will provide a model for future hybrid conferences.

Public health relevance
NARRATIVE The 2022-2024 Summer Biomechanics, Bioengineering, and Biotransport Conferences provide an opportunity to share current bioengineering research. Our goal is to increase the participation of students from groups traditionally underrepresented in bioengineering. To achieve this goal, we ask for NIH support to creating a hybrid meeting with in-person talks, posters, workshops, networking and social events as well as virtual content, including recordings of in-person plenary lectures and oral sessions as well as online posters.